Effects of Opioid Use Disorder in Pregnancy on Long-Term Maternal and Child Outcomes

Project Summary: In the US, 14-21% of pregnant women are exposed to opioids during pregnancy. This re-
flects a doubling of prescribed opioid use and opioid use disorder (OUD) in pregnancy in the past dec-
ade. Opioid relapse during pregnancy and after delivery is high due to post-partum depression and other psy-
chosocial factors. In parallel, neonatal abstinence syndrome (NAS) rates have increased more than 3 to 20 fold
since 2000. Every 25 minutes, a baby is born dependent to opioids in the US. Children exposed to opioids pre-
natally and in the neonatal period are at risk of opioid misuse later in life, and may develop cognitive, behavior-
al and neurodevelopmental problems. All these preventable public health crises confer a significant societal
and economic burden, with loss of productive life. Despite the high prevalence of exposure to opioids, little is
known about the factors predisposing to poor maternal outcomes, and neurodevelopmental outcomes in chil-
dren with maternal OUD. Further, the effect of in-utero opioid exposure on placental function, fetal maturation
and neonatal brain activity are unknown. Tackling maternal opioid misuse and NAS requires a comprehensive
understanding of multiple maternal-infant factors. There is a critical need for early and targeted identification of
pregnant women with OUD at risk for relapse and poor long term maternal and childhood outcomes. Our long-
term goals are to reduce future maternal OUD and relapse on opioid maintenance therapy, decrease severity
of NAS, personalize NAS treatment, and improve neurodevelopment in children with in-utero opioid exposure.
The objective of this proposal is to determine multi-factorial genetic, psychosocial predictors of opioid related
maternal and infant outcomes using rigorous prospective longitudinal design, innovative combinatorial phar-
macogenetic approach, fetal MRI and neonatal brain resting state functional MRI analysis. Our earlier work
showed that maternal/neonatal genetic variations and opioid-pharmacogenetics were associated with NAS se-
verity and adverse effects of opioids. Our preliminary data show that children treated for NAS had significantly
worse cognitive function at two years of life. Based on our previous results, we hypothesize that a combination
of maternal and infant genetic profile, maternal psychosocial factors, maternal opioid treatment response, fetal
and neonatal neurodevelopment and NAS treatment will affect maternal and childhood outcomes with prenatal
opioid exposure.The specific aims are to: 1) Identify high-risk genetic profiles and psychosocial factors in preg-
nant women with opioid use disorder, and predisposing to poor maternal opioid maintenance treatment out-
comes; 2) Determine maternal-infant genetic profiles and maternal opioid treatment factors predicting adverse
fetal development, severity of NAS, and neonatal brain function; and 3) Develop predictive models for maternal
opioid relapse, and poor long-term neuro-developmental outcomes in children with in-utero opioid exposure.
Critical new knowledge from this research will enable safe, effective treatment of maternal-infant opioid expo-
sure and neurodevelopmental outcomes by enabling proactive risk predictions and personalized interventions.

Public health relevance
Project Narrative This research has significant public health relevance because it will improve understanding of how genes, psychological and socio-environmental factors influence opioid use in pregnancy. We will use novel magnetic resonance imaging (MRI) tools to determine effects of opioid exposure on the placenta, fetus and the neonatal brain. This innovative research has high impact because it will provide robust tools to identify pregnant women at high risk for failed opioid maintenance therapy including relapse, and infants at high risk for severe opioid withdrawal and poor neurodevelopmental outcomes. Results of this study will help to personalize opioid management therapy in millions of mothers and infants to optimize important and long-term outcomes.